Structural Studies of IgE Receptors

DESCRIPTION (provided by applicant): IgE antibodies bind the high affinity IgE Fc receptor (FcεRI), found primarily on mast cells and basophils, and trigger inflammatory cascades of the allergic response. Inhibitors of IgE:FcεRI binding have been identified and an anti-IgE therapeutic antibody (omalizumab) is used to treat severe allergic asthma. However, preformed IgE:FcεRI complexes that prime cells prior to allergen exposure dissociate extremely slowly and cannot be disrupted by classical competitive inhibitors. We demonstrated that two DARPIn inhibitors not only block IgE:FcεRI interactions, but they actively disrupt preformed IgE:receptor complexes by a mechanism known as facilitated dissociation. The results indicate that IgE-Fc conformational fluctuations and states, alone and in complexes with FcεRI, can be targeted by novel, non-classical inhibitors that can actively disassemble IgE:FcεRI complexes to block the allergic response. In this proposal, we will explore the mechanism of inhibition and facilitated dissociation of IgE:FcεRI complexes by the DARPins and omalizumab in order to better define the major parameters that govern the efficiency of disruptive inhibition and receptor complex dissociation. The proposed experiments will provide greater insight into the dynamics of IgE:FcεRI complexes, stabilization of receptor complexes mediated by the IgE-Fc Cε2 domains and provide a foundation for designing improved disruptive inhibitors with greater potency and efficiency of complex disassembly.

Public health relevance
PUBLIC HEALTH RELEVANCE: The interaction of IgE antibodies with the high affinity receptor (FcεRI) on mast cells plays a central role in initiating allergic reactions. Most of the IgE antibodies are captured by Fc�RI and stably resident on mast cells, priming the cells to react rapidly upon encountering allergens. Anti-IgE antibody therapy using omalizumab has demonstrated clinical benefit by blocking complex formation between the IgE and Fc�RI, but omalizumab treatment is not designed to disrupt the tightly bound, preformed complexes on cells. It is therefore not used to treat acute allergic responses. We have demonstrated that two engineered anti-IgE inhibitors, DARPins, actively disrupt IgE:Fc�RI complexes. This novel class of inhibitors raises the possibility that IgE could be actively stripped from the surface of mast cells during an acute allergic reaction, disconnecting allergen recognition from the harmful cellular response. In this proposal, we will further examine the mechanism of disruptive inhibition of the DARPins in order to better understand the principles governing this mechanism and to enable the development of novel therapeutic interventions.